Biospecimen-Core

Project Summary
Senescent cells (SnCs) accumulate with age and in various chronic disease states and clearly contribute to
driving morbidity and mortality in model organisms. Drugs that selectively eliminate SnCs (“senolytics”) were first
developed by our team and have been demonstrated to reduce frailty, extend median lifespan, and attenuate
morbidity in murine models of numerous age-related diseases. However, SnCs also play a role in wound healing
and tissue remodeling. To advance senolytics to their greatest potential, then, it is imperative to understand more
about SnCs in humans with healthy aging. As part of SenNet, the proposed Minnesota Tissue Mapping Center
(MN TMC) has selected four tissues for identification, characterization, and spatio-temporal analysis of
senescence: adipose, skeletal muscle, liver, and ovarian tissues. These tissues were selected because of the
scientific expertise at UMN and Mayo Clinic in the biology of these organs, evidence of increased senescence
with age, and availability of biobanked specimens as well as surgical access to fresh tissues from healthy
individuals. The overall goal of the Biospecimen Core (BSP), co-directed by Dr. Sayeed Ikramuddin, Chair of
the UMN Department of Surgery, and Dr. Oyedele Adeyi, Professor of Laboratory Medicine and Pathology, is
to provide the tissues and blood for PBMC isolation to the Biological Analysis Core (BAC) for bulk, single cell,
and spatial analysis of human SnCs for subsequent multi-plex analysis of the results by the Data Analysis Core
(DAC). The BSP will leverage their strong track
record of obtaining high-quality, well-annotated human samples
from non-chronically diseased individuals who are metabolically characterized and with appropriate diversity in
gender, race, socio-economic status, ethnicity, and other relevant diversity parameters. The BSP will also
provide access to
UMN’s specimen procurement network (BioNet) that has ~70,000 archival tissues (frozen,
FFPE) and biofluids (frozen) collected for research, including several adipose depots, several muscles, liver from
organ donors, and healthy ovarian tissues removed because of benign lesions. In addition, the BSP has access
to tissues within the Rochester Epidemiology Project, which encompasses the medical records of all citizens
living in Olmsted County, MN since 1966, along with archived biological specimens. The Aims of the BSP are
to: 1) Prepare and maintain all regulatory materials supporting human tissue collection; 2) Recruit and consent
patients of different ages for this project; 3) Characterize the metabolic health of enrolled participants; 4)
Coordinate with BioNet for intraoperative specimen collection, annotation, and storage of tissues; 5) Procure and
annotate high quality target tissues along with relevant biofluids; 6) Longitudinally follow patients for which weight
loss and bariatric surgery are metabolic perturbations; 7) Disseminate the samples to MN TMC BAC; and 8)
Partner with SenNet to share tissues and to develop shared patient consent and tissue collection protocols with
appropriate Ethical, Legal and Social Implications and quality control and assurance considerations.